ANALYSIS OF HEART RATE VARIABILITY

Spectral analysis of heart rate variability in the respiration-related high frequency range, to measure parasympathetic activity during weight gain and weight loss.